miR6891-5p-regulated X skewing in Sjögren's Disease: molecular mechanism, reversal strategies, and clinical significance

ABSTRACT
As the most female-predominant autoimmune disease with a female-to-male ratio of 14:1, primary Sjögren's
Disease (SjD) provides a unique opportunity to address the knowledge gap in the molecular basis of sexual
dimorphism in autoimmunity. Emerging findings support the role of the X chromosome in impacting the female
bias in SjD. However, the exact molecular underpinnings of X-chromosomal dysregulation in SjD remains
elusive.
Using minor salivary gland-derived mesenchymal stromal cells (MSCs), we discovered striking, global
skewing of X-linked genes in SjD, but not control, subjects. Mechanistically, we identified miR6891-5p, a HLA-
encoded noncoding RNA, as a critical gatekeeper of X chromosomal allelic balance in MSCs. In pilot studies,
we demonstrated that SjD MSCs exhibited reduction in miR6891-5p expression, that inhibition of miR6891-5p in
control MSCs led to skewing, and that restoration of miR6891-5p expression in SjD MSCs reversed skewing of
X-linked genes. On the chromatin level, miR6891-5p expression restricted CTCF activity in its restoration of
allelic balance. Focusing on the phenomenon of X skewing, in this project we propose to address three broad
questions, namely 1) the molecular mechanism of miR6891-5p-CTCF-mediated regulation of allelic balance, 2)
targeted strategies to reverse skewing in SjD, and 3) the clinical significance of X skewing in SjD patients.
Collectively, we will test the hypothesis that miR6891-5p loss leads to X skewing in SjD and targeting of the
miR6891-5p pathway has the potential to restore X-chromosomal allelic balance by the following aims:
Aim 1. Establish the molecular mechanism of miR6891-5p-regulated X skewing and identify molecular
targets to correct skewing
Aim 2. Determine the potential of reprogramming as a strategy to globally restore allelic balance in SjD
Aim 3. Establish the relationship between miR6891-5p-regulated X skewing and SjD pathogenesis
With successful completion of the work proposed, we will have gained insights into the molecular basis
underlying sexual dimorphism in SjD. By establishing the miR6891-5p-regulated pathway as a central regulator
of X chromosomal allelic balance, we will identify molecular and cellular targets for the reversal of X skewing and
personalized management of SjD.

Public health relevance
PROJECT NARRATIVE This study is designed to advance our understanding in the molecular basis underlying sex differences in autoimmune pathogenesis. It focuses on dysregulation of the sex chromosome and in particular, the skewing of genes on the X chromosome. By delineating the molecular events leading to skewing, this project has the potential to provide novel, pharmacologically targetable pathways for the clinical management of Sjögren's Disease in a personalized manner.